Combining B. thuringiensis crystal proteins with small molecule anthelmintics to combat parasitic nematode resistance

New treatments are urgently needed for parasitic gastrointestinal nematodes (GINs; hookworms, whipworms,
roundworms) that infect ~1.5 billion people and cause significant morbidity in children, pregnant women, and
working adults. The main drug used against GIN in mass drug administration (MDA) is albendazole (ABZ),
with increased use of ivermectin (IVM) and consideration of the experimental drug emodepside (EMO). MDA
with ABZ has not been curative, and IVM and EMO also have limitations. Thus, controlling GINs remains a
critical unmet medical need. Experience with HIV, tuberculosis, and malaria shows that well-designed drug
combinations can suppress resistance and enhance efficacy. Especially effective combinations are synergistic
and show collateral sensitivity (CS), where resistance to drug A increases susceptibility to drug B.
We have pioneered the development of crystal (Cry) proteins from the soil bacterium Bacillus thuringiensis
(Bt) as safe, effective, and affordable next-generation anthelmintics to control GINs. For over 60 years, Cry
proteins have controlled insects that vector disease and damage crops, including use in >100 million hectares
of transgenic crops grown annually. Oral Cry5Ba treatment is safe for mammals and highly effective against
GINs in rodents, dogs, sheep, pigs, and horses. We have now identified five other anthelmintic Cry proteins.
Cry5Ba interacts synergistically and shows CS with nicotinic acetylcholine receptor agonist anthelmintics.
Cry5Ba also synergizes with ABZ against all GINs and shows CS to EMO- and IVM-resistant nematodes. These
data demonstrate that Cry proteins have excellent combinatorial properties with small molecule anthelmintic
drugs. We propose to discover optimal combinations between six anthelmintic Cry proteins and three small
molecule drugs (ABZ, IVM, or EMO) to suppress drug resistance and greatly improve efficacy.
Three major aims will be pursued: Aim 1. Find strong synergistic interactions. Checkerboard design studies
will be carried out with 6 Cry proteins x 3 small molecule drugs against three major GINs: Ancylostoma
ceylanicum hookworms, Trichuris muris whipworms, and Ascaris suum roundworms. Synergy will be
quantified with the ZIP synergy model. Aim 2. Find strong CS relationships. (1) Quantify the sensitivity of ABZ,
IVM, and EMO-resistant Caenorhabditis elegans to six Cry proteins and the sensitivity of Cry-resistant C.
elegans to ABZ, IVM, and EMO. (2) Quantify the sensitivity of ABZ- and IVM-resistant Haemonchus contortus
to (a) Cry proteins and (b) Cry protein – small molecule drug combinations using a larval development assay.
The data from Aims 1+2 will be integrated to design and test optimal Cry protein-drug combinations for in vivo
synergy against parasitic infections, mechanistic studies using transcriptomics, and resistance management via
computer modeling to optimize strategies for sustaining efficacy against GINs. The results will identify optimal
combinations of Cry proteins and small molecule drugs to suppress drug resistance and increase efficacy,
thereby providing durable relief from the human suffering caused by GINs.

Public health relevance
Project narrative Gastrointestinal nematode parasites (aka Soil-transmitted helminths) are amongst the most prevalent and disease-causing parasites on earth for humans and animals, with infection leading to malnutrition, adverse pregnancy outcomes, low worker productivity, and permanent growth stunting and cognitive impairment. Very few drugs are approved to treat them, and those that are used are prone to parasite resistance and have inadequate efficacy. Here, we study combinations of safe anti- nematode proteins from a natural soil bacterium with the small molecule drugs now used (or proposed to be used) to treat gastrointestinal nematode parasites in order to give rise to new deworming combination therapies that would suppress parasite resistance and greatly increase efficacy at curing the infections.